Administrative Core (Core A)

The responsibilities of the Administrative Core are to implement the goals and strategies summarized in the Program Overview that were devised to transition our COBRE center towards long term sustainability. The Administrative Core will be responsible for oversight and management of all funds and proposed core and research activities associated with the Phase III COBRE renewal program. This Core will be the center for business management, scheduling, organizing the annual CDBC symposium, statewide outreach, program development, preparing the annual progress report and communication among scientific core directors, advisors, the central administration and all COBRE and non-COBRE participants. The Administrative core is directed by the PI, Roger Markwald, with assistance of the Program Coordinator (PC), Dr. Andy 11Vessels whose main responsibilities will be to find ways to integrate core operations, trouble-shoot, evaluate user metrics, assess progress towards implementation of the user fee programs, direct the Pilot Project Program and coordinate plans for seminars and other outreach activities in support of core facilities. A program manager, Ms. Evelyn Fabunan, will handle day-to-day ordering and fiscal issues. The Internal Advisory Committee is the primary operational arm of the Administrative Core and will meet biweekly to assess progress, performance of core functions, ways to improve core usage and develop extramural funding. Its permanent members include the three core directors and four ad hoc MUSC scientists who will primarily assist with resolving conflicts and selecting pilot projects for the voucher program The External Advisory Committee is composed of senior scientists with experience in directing core facilities and the cardiac theme of our COBRE center. They will annually review activities of the Administrative Core and the IAC and make recommendations whenever solicited for improving core performance and programmatic development The Administrative Core is committed to making our science and technology cores in imaging, gene function and proteogenomics & bioinformatics the foundational pillars for sustaining, extending the outreach and the scientific competitiveness of our cardiovascular developmental biology center.

Public health relevance
The Administration Core provides sound organizational structure and a coordinated administrative framework to ensure good management, integration, and oversight of the proposed COBRE/CDBC program